Whole Blood Point of Care Metabolic Measurement

Parent Grant: HD107897
PA-21-345 Administrative Supplement for Long-Term Investigator
Project Summary
Sequitur Health Corp. is performing research for a National Institutes of Health Phase II Small Business
Innovation Research (SBIR) Parent Grant: HD107897 to develop a point of care system for measurement of an
analyte directly from a drop of whole blood. The Sequitur system has >90% accuracy for measurement of this
analyte compared to the U.S. Food and Drug Administration approved clinical laboratory instrument method for
measuring this analyte.
Sequitur Health Corp. is a women-owned small business that is partially owned by a female from a
socially disadvantaged group, as defined by the United States Small Business Association (U.S. SBA).
Sequitur will use this supplement to hire a Ph.D.-level Hispanic female, who is from a socially disadvantaged
group as defined by the U.S. SBA. This Long-Term Investigator will contribute to the completion of the parent
Phase II SBIR award ongoing research Aims. The immediate impact of this administrative supplement will be
to increase diversity in the United States Small Business workforce. The long-term impact of this administrative
supplement will be to help the individual hired contribute to the ongoing research, develop more skills, and
launch a successful career as an entrepreneurial-minded independent scientist.

Public health relevance
Parent Grant: HD107897 PA-21-345 Administrative Supplement for Long-Term Investigator Project Narrative Relevance to Public Health: Sequitur Health Corp. is performing research under a National Institutes of Health Phase II Small Business Innovation Research (SBIR) Parent Grant: HD107897 to develop a point of care system for measurement of an analyte directly from a drop of whole blood for improved detection and management of specific disorders. This administrative supplement will increase diversity in the United States Small Business workforce by enabling Sequitur to hire a Ph.D. scientist who is a Hispanic female (a socially disadvantaged person) to contribute to the parent Phase II SBIR award ongoing research. This Ph.D. scientist will contribute to research to create improved point of care measurement of this blood marker that will improve quality of life by enabling timely use of known effective treatments to reduce this blood marker in people affected by the disorders.